ADMINISTRATIVE CORE

PROJECT SUMMARY/ABSTRACT
The Center for Cancer Research and Therapeutic Development (CCRTD) at Clark Atlanta University (CAU) has
a new interest in expanding capacity to explore translational mechanisms addressing prostate cancer disparities
in African-American men. Congruent with this focus are the needs to augment institutional research capacity in
basic biomedical and social/behavioral research; enhance competitiveness for obtaining extramural funding;
support development of emerging and early stage investigators; integrate campus-wide activities and
relationships to increase the quality of health disparities research; and continue to crystallize relationships with
Atlanta community-based stakeholders to inform, guide and collaborate with our research activities. The
Administrative (Admin) Core will be responsible for the overall management of the proposed program. The Admin
Core will be comprised of the Principal Investigator/Program Director, Program Manager II, Biostatistician and
Bioinformatician, and will be responsible for delivering services to the entire RCMI program and the CCRTD. The
Specific Aims are: 1) provide leadership necessary for the planning, implementation, management and
assessment of all RCMI activities consistent with achieving proposed mission and goals; 2) provide
administrative management for procurement, human resources and financial oversight; 3) facilitate workshops,
seminars, and activities that will enhance scientific and community engagement, and productivity among CCRTD
researchers; 4) serve as an intermediary between all components of the RCMI program, NIMHD university
administration and other external constituents; and 5) Support recruitment of two (2) independently funded faculty
in social/behavioral health disparity research in cancer.
The Admin Core will be directed by the PI/PD to provide administrative leadership, oversight, accountability,
integrative coordination, communication, mentorship, programmatic assessment and evaluation for all proposed
cores and activities. The Program Manager III will assist in oversight and coordination of all activities within
proposed cores, professional development activities and program evaluation. The Biostatistician and
Bioinformatician will be invaluable resources to enhance the competitiveness and rigor of research activity in the
CCRTD. The unique and collective strengths of the cores, innovative research projects, excellent resources,
professional development plan, and mentoring activities will provide comprehensive, integrated and centralized
infrastructure, and high-quality capabilities for advanced prostate cancer and biomedical research innovation
and synergistic community engagement that directly impact the medical, social and behavioral health of African-
American men. The Admin Core is critical to synergizing biomedical research infrastructure within the CCRTD
and CAU to provide the necessary support to our investigators that are addressing cancer-based health concerns
and needs of African-American men.